Regulation of a cardiac b1AR/SERCA2 complex in heart failure

Abstract
Desensitization of b1-adrenergic receptors (b1ARs) is a hallmark of heart failure (HF), in which b1ARs on the
plasma membrane (PM-b1AR) undergo endocytosis. The loss of PM-b1AR leads to impaired cAMP-PKA activity
associated with reduced ejection fraction in HF. Despite decades of efforts that have primarily aimed to restore
the cell surface b1AR signaling in failing hearts, effective pharmacotherapy for HF remains an unmet clinical
need. Distinct from most prior studies that focused on bAR at the PM, accumulating evidence of bAR signaling
inside myocyte indicates potential implication in HF. We aim to reveal an internal b1AR signaling at the
sarcoplasmic reticulum (SR) critical for regulating cardiac contractility, which is desensitized in HF. We recently
reported a pool of functional b1ARs on the SR (SR-b1AR). The SR-b1AR is activated by catecholamines entering
cells via primarily organic cation transporter 3. We found that monoamine oxidase A (MAOA), an enzyme
responsible for the degradation of catecholamines, is significantly increased in human HF. Thus, the elevated
expression of MAOA essentially restricts the access of catecholamines to the SR-b1AR in HF despite increased
sympathetic drive. In this proposal, we hypothesize that 1) activation of the SR-b1AR is fine-tuned by MAOA for
enhancing cardiac E-C coupling in physiological stress; 2) the increased expression of MAOA in HF exacerbates
b1AR signaling desensitization and contributes to depressed contractility. We propose that MAOA inhibition re-
sensitizes the SR-b1AR signaling in failing myocytes and rescues E-C coupling and cardiac contractility in HF.
We will apply integrated experimental approaches to test the hypotheses. Aim 1 MAOA controls the access of
catecholamines to the SR-b1AR and cardiac inotropy. Aim 2. Cardiac b1ARs undergo translocation from the PM
to the SR under chronic adrenergic stimulation in HF. Aim 3. Inhibition of MAOA rescues the SR-b1AR signaling
and cardiac contractility in HF. Distinct from most studies focusing on adrenergic signaling on the PM, this study
aims to unravel a novel local SR adrenergic signaling in the regulation of cardiac E-C coupling and present
MAOA as a potential therapeutic target to rescue depressed cardiac contractility in HF.

Public health relevance
Narrative and Public Health Relevance Heart failure is a leading cause of mortality in the United States. Cardiac b1 adrenergic signaling is a critical regulator of cardiac function. We aim to characterize a novel pool of intracellular b1 adrenergic receptor that is essential for cardiac function. We aim to find how to target this pool of receptors in enhancing cardiac function in heart failure.